(PQA1) Mechanism of Vitamin D Chemoprevention Against Colon Cancer

DESCRIPTION (provided by applicant): The goal of this application is to address RFA-CA-12-015 PQA1: What is the molecular mechanism by which a drug that is chronically used for other indications protects against cancer incidence and mortality? Vitamin D (VD) is a widely and chronically used supplement for maintenance of bone health and for treatment of osteoporosis, but a growing body of evidence has indicated that VD has potent chemopreventive effects against colon cancer by unknown mechanisms. Thus the central question to be addressed is: What is the molecular mechanism by which Vitamin D prevents colon cancer? Colon cancer is a leading cause of cancer- related deaths in the US. Low VD status is associated with increased colon cancer incidence, chemopreventive effects of VD have been demonstrated in colon cancer models, and large randomized clinical trials are being conducted to evaluate VD's chemopreventive efficacy against colon cancer in humans, but the mechanism underlying VD's anti-colon cancer activity remains to be defined. Secondary bile acids (BA) are potent colon cancer promoters. VD is known to affect colonic secondary BA levels by regulating host and colonic bacterial BA metabolism. Therefore we hypothesize that VD regulation of secondary BA levels is a key molecular mechanism underlying VD's chemopreventive activity against colon cancer. Moreover, the tumor-promoting secondary BA lithocholic acid (LCA) can also activate the vitamin D receptor (VDR), and LCA-VDR signals, like VD-VDR signals, also promote secondary BA catabolism by inducing Cyp3A, which can paradoxically limit LCA's tumor-promoting effects. Therefore we also hypothesize that VDR signals activated by VD or LCA limit secondary BA levels, thus mitigating tumor promotion by BAs. We will test these hypotheses using colon cancer models in genetically engineered mice with altered vitamin D hormone or VDR levels, and in gnotobiotic mice with altered bacterial secondary BA production. In Aim 1 we will determine the VDR-dependent host and microbe mechanisms that regulate Western diet-induced secondary BAs and colonic tumorigenesis. We will assess secondary BA levels and colonic tumorigenesis in WT, VDR(-/-) and transgenic mice over-expressing epithelial VDR that are fed Western diet or VD supplemented diet. In Aim 2 we will dissect the role of VD- independent LCA-VDR signals in colonic tumorigenesis. We will compare effects of Western diet or dietary LCA on secondary BAs and colonic tumorigenesis in WT, VDR(-/-), Cyp27b1(-/-) and VDR(-/-)/Cyp27b1(-/-) mice. Cyp27b1(-/-) and VDR(-/-)/Cyp27b1(-/-) mice cannot synthesize VD hormone, allowing us to dissect the chemopreventive effects of LCA-VDR signals without confounding effects of endogenous VD hormone. In Aim 3 we will assess the role of microbial 7α-dehydroxylase (7-DH) in VD chemoprevention. We will compare tumorigenesis in gnotobiotic mice mono-associated with Lactobacillus acidophilus lacking 7-DH to mice also associated with Clostridium scindens expressing 7-DH fed Western diet or diet supplemented with VD. These studies will greatly advance our understanding of chemopreventive mechanisms of VD against colon cancer.

Public health relevance
PUBLIC HEALTH RELEVANCE: Colon cancer is a leading cause of cancer-related deaths in the US. Western diets increase the risk of colon cancer in part by increasing colonic bile acids. Vitamin D is a widely and chronically used supplement for maintenance of bone health and for treatment of osteoporosis. A growing body of evidence has indicated that vitamin D has potent chemopreventive effects against colon cancer by unknown mechanisms. Since vitamin D controls several key steps in bile acid metabolism, the goal of this proposal is to use genetically engineered mice to address whether vitamin D suppresses colon cancer by altering bile acid metabolism. __SpecificAimsTextDelimiter__ SPECIFIC AIMS In this application we propose to specically address RFA-CA-12-015 PQA1: What is the molecular mechanism by which a drug that is chronically used for other indications protects against cancer incidence and mortality? Vitamin D is a widely and chronically used supplement for maintenace of bone health and for treatment of osteoporosis. A growing body of evidence, however, has indicated that vitamin D has potent chemopreventive effects against colon cancer by unknown mechanisms. So the central question to be addressed in this proosal is: What is the molecular mechanism by which Vitamin D prevents colon cancer? Colon cancer is a leading cause of cancer-related deaths in the US. While the cause of colon cancer is complex, increasing attention has focused on low Vitamin D (VD) status as a major potential risk factor. VD is mainly synthesized in the skin and converted to 25-hydroxyvitamin D (25(OH)D), the main circulating VD metabolite widely used as a indicator of VD status. 25(OH)D is converted by renal 1α-hydroxylase (Cyp7b1) to 1α,25-dihydroxyvitamin D (1,25(OH)2D3), the physiological hormone that activates the vitamin D receptor (VDR). Low VD status is associated with increased colon cancer incidence in epidemiological studies, and the chemopreventive effects of VD have been demonstrated in colon cancer models. The evidence has prompted large randomized clinical trials to evaluate the chemopreventive efficacy of VD supplementation against colon cancer. The mechanism underlying VD's anti-colon cancer activity, however, remains to be defined. Secondary bile acids (BA) are potent promoters of colon cancer, which explains in part why high fat-containing Western diets increase colon cancer incidence. Recent studies show that VD affects colonic secondary BA levels by regulating host and colonic bacterial BA metabolism. As VD inhibits host hepatic BA synthesis (via suppressing Cyp7a) and increases host small bowel BA absorption (via regulating intestinal regulators Asbt, FXR, PXR, Shp, FGF15), VD could reduce colonic delivery of cholic acid, a major inducer of bacterial 7α-dehydroxylase (7α-DH), which dehydroxylates primary BAs to generate tumor-promoting secondary BAs in the colon. VD also induces antimicrobial peptides (AMP) that can indirectly modulate bacterial 7α- DH activity (Fig. 1). We hypothesize that VD regulation of secondary BA levels is a key molecular mechanism underlying VD's chemopreventive activity against colon cancer. There have been no studies to dissect VD- regulated host-microbe interactions that control secondary BA metabolism in colonic tumorigenesis. Interestingly, the secondary BA lithocholic acid (LCA) is also a VDR ligand. LCA-VDR signals promote secondary BA catabolism by inducing Cyp3A, which could paradoxically limit LCA's tumor-promoting effects (Fig. 1). Our preliminary data showed that VDR deletion led to decreased Cyp3A and increased colonic BAs and tumor burden, whereas in wild-type (WT) mice dietary VD increased Cyp3A and decreased colonic BAs. These observations prompted us to hypothesize that VDR signals activated by VD or LCA limit secondary BA levels, thus mitigating tumor promotion by BAs. We will dissect the role of host and microbial regulation of secondary BA metabolism in VD chemoprevention using experimental colon cancer models (azoxymethane and Cdx2-ApcLoxP models) in genetically engineered mice with altered vitamin D hormone or VDR levels, and in gnotobiotic mice with altered bacterial secondary BA production. Aim 1. To determine the VDR-dependent host and microbe mechanisms that regulate Western diet- induced secondary BAs and colonic tumorigenesis. We will assess secondary BA levels and colonic tumorigenesis in WT, VDR(-/-) and transgenic mice over-expressing epithelial VDR that are fed Western diet or VD supplemented diet. We will correlate VD/VDR signals with other BA regulators, including bacterial bile acid 7α-DH, and host intestinal Cyp3a1 and AMP levels, hepatic Cyp7a1, gut nuclear receptors FXR, PXR and Shp, intestinal bile acid transporters (Asbt) and fibroblast growth factor15 (FGF15). Aim 2. To dissect the role of VD-independent LCA-VDR signals in colonic tumorigenesis. We will compare effects of Western diet or dietary LCA on secondary BAs and colonic tumorigenesis in WT, VDR(-/-), Cyp27b1(-/-) and VDR(-/-)/Cyp27b1(-/-) mice. Cyp27b1(-/-) and VDR(-/-)/Cyp27b1(-/-) mice cannot synthesize 1,25(OH)2D3 and thus these mice will allow us to dissect the chemopreventive effects of LCA-VDR signals, without confounding effects of endogenous active VD hormone. Aim 3. To assess the role of microbial 7α-dehydroxylase in VD chemoprevention. Increasing attention has been focused on colonic bacteria in health and disease. We will compare tumorigenesis in gnotobiotic mice mono-associated with Lactobacillus acidophilus lacking 7α-DH to mice also associated with Clostridium scindens expressing 7α-DH fed Western diet or diet supplemented with VD. We speculate that tumor burdens in mice harboring bacteria capable of secondary BA synthesis will be increased and that VD will inhibit this.